PET to Assess Post-TB Lung Disease in TB Patients with / without HIV coinfection

Mycobacterium tuberculosis remains the second leading cause of death from a single infectious agent
globally, after COVID-19. The risk of developing tuberculosis (TB) is substantially higher in human
immunodeficiency virus (HIV) coinfected individuals, with TB and HIV potentiating each other, causing
substantial declines in immune function. Globally in 2022, there were an estimated 1.3 million deaths and
10.6 million new cases due to TB. Importantly, it is estimated that more than 58 million patients have survived
TB in this century alone. However, unlike other respiratory infections, many patients with TB have permanently
damaged tissues and successful TB treatments only transition these patients from harboring a communicable
infectious disease, to a syndrome of chronic pulmonary morbidity. This syndrome, commonly referred as post-
TB lung disease, affects ~50% of patients with pulmonary TB, who develop chronic adverse outcomes beyond
the TB treatments, including bronchiectasis, poor lung function and respiratory symptoms. Although post-TB
lung disease remains poorly characterized, it is primarily mediated by M. tuberculosis-induced tissue
destruction (necrosis) and subsequent adverse lung tissue remodeling and fibrosis, which in addition to
causing pulmonary disease, also impairs vascular supply and reduces antibiotic access to the infected TB
lesions. Currently, there are no approved treatments to prevent post-TB lung disease.
We have characterized lung disease in animal models of TB to develop adjunctive treatments that prevent
post-TB lung disease. Importantly, we have also developed and utilized novel, clinically translatable positron
emission tomography (PET)-based imaging to longitudinally profile lesional characteristics in animal models
and TB patients: 11C-rifampin (chemically identical to rifampin) PET to measure tissue antibiotic area under the
curve exposures (Ordonez . . . Jain. Nat Med. 2020) and 18F-FAPI-74 PET for monitoring fibrosis. Our central
hypothesis is that 18F-FAPI-74 PET could be used as a noninvasive biomarker to assess post-TB lung
disease and fibrosis in TB patients. Additionally, we hypothesize that lesions with significantly
reduced 11C-rifampin exposures in TB patients within 6-weeks of treatment initiation (early time-point)
will develop post-TB lung disease sequelae at those sites after treatment completion.
Here, we will leverage our expertise in TB pathogenesis and molecular imaging to conduct longitudinal,
observational studies to visualize lesional rifampin exposures and lung fibrosis in patients with recently
diagnosed pulmonary TB, with or without HIV coinfection, within 6-weeks of initiation and after completion of
TB treatments. Our goals are to better characterize post-TB lung disease sequelae and identify key factors,
such as lesional antibiotic exposures in TB patients that could subsequently lead to post-TB lung disease. In
the future, we anticipate that these imaging approaches could be used to noninvasively characterize post TB-
lung disease and evaluate novel treatments that prevent or mitigate post TB-lung disease.

Public health relevance
Our overall goals are to leverage our expertise in molecular imaging, TB pathogenesis, and clinical translation of PET ligands to develop cutting-edge, clinically translatable imaging technologies to better characterize post- TB lung disease and identify key factors, such as lesional antibiotic exposures in patients with pulmonary TB, with or without HIV coinfection.